Chemical Engineering of Extracellular Vesicles for Enhanced Glioblastoma Therapy: Undergraduate Biomedical Research at Southern Utah University

ABSTRACT
Glioblastoma, a highly aggressive brain cancer with a mere 15-month survival rate, impacts over 15,000
individuals annually in the US, inflicting considerable financial strain and a morbidity rate surpassing 30%.
Traditional treatments such as surgery, radiation, and the chemotherapy drug temozolomide often yield
restricted remission due to barriers posed by tumor inaccessibility, microenvironment intricacies, and drug
resistance, leading to significant side effects. Overcoming these challenges requires innovative approaches. A
promising avenue involves harnessing nanosized extracellular vesicles (EVs) for drug delivery. EVs, with their
inherent involvement in cellular communication, offer an enticing solution. Their biological origin circumvents
issues of immunogenicity, toxicity, and clearance frequently encountered by synthetic nanoparticle systems.
EVs are readily isolable from bodily fluids across species, finding abundant availability in bovine milk. By
leveraging EVs' natural functions, including enhanced targetability and cellular communication, the potential for
successful therapy delivery increases substantially. Incorporating specific targeting moieties, such as the
cytolytic peptide Pep-1-Phor21, enhances EV efficacy; this peptide targets the overexpressed Interleukin-13
Receptor α2 on glioblastoma cells. This synergistic coupling of Pep-1-Phor21 and bovine milk-derived EVs
promises a more effective targeted delivery of encapsulated chemotherapeutics such as temozolomide. Our
hypothesis is that bovine milk-derived EVs can be engineered with Pep-1-Phor21 and encapsulated
temozolomide to enhance the demise of glioblastoma cells. This proposal outlines three aims: 1)
determine the capability of Pep-1-Phor21-modified bovine milk-derived EVs to cross the blood-brain barrier; 2)
evaluate the efficacy of Pep-1-Phor21-modified EVs loaded with temozolomide in delivering their payload to
glioblastoma cells; and 3) determine the optimal dosage and internalization route of
Pep-1-Phor21-temozolomide EVs in vitro. This work not only demonstrates the adaptability of bovine milk EVs
but also advances EV-based drug delivery, ultimately enriching the landscape of glioblastoma treatment
options.

Public health relevance
Public Health Relevance Statement This research is highly relevant to public health as it addresses the urgent need for improved treatment options for glioblastoma, a devastating brain cancer with a short survival rate and significant financial burden. By harnessing nanosized extracellular vesicles (EVs) from bovine milk and engineering them with a dual Pep-1-Phor21 cytolytic and targeting peptide and encapsulated temozolomide, a first-line chemotherapy drug, this study offers a promising approach for enhancing the targeted delivery of therapies to glioblastoma cells. This innovative and versatile approach could offer a more effective and targeted therapy for glioblastoma, potentially prolonging survival and reducing the morbidity associated with current treatments, thus significantly enhancing public health outcomes for affected individuals.